Dynamic architecture and function of microtubule networks

Project Summary
I request funds to purchase several key components in order to add an advanced functionality of
an existing live-cell imaging microscope system. Specifically, I propose to add an NSPARC
(confocal multi-array detector) to the Nikon Eclipse Ti2 microscope system currently equipped for
Total Internal Reflection Fluorescence (TIRF) microscopy. This would allow for low-light 3D
detection of ultra-fine structural information beyond the resolution limit. This additional microscope
capacity will allow for super-resolution imaging of subcellular dynamics in live samples of various
thickness, including single cells and multicellular tissue samples. This equipment is needed to
achieve goals of the parent grant with deep insights and a cutting-edge data quality.

Public health relevance
Narrative This is an application for an administrative supplement for NIGMS R35GM127098 MIRA grant, with a goal to add a confocal scanner and multi-array detector (NSPARC) to the existing Nikon TEi2-E microscope, currently equipped for TIRF imaging. This would allow for low-light 3D detection of ultra-fine structural information beyond the resolution limit and significantly push forward every research direction in the Kaverina laboratory.